Examining the impact of state laws on intimate partner violence

Intimate partner violence (IPV) is common with over 7% of U.S. women reporting physical or sexual violence,
and/or staking in the past year. Moreover, nearly 10% of pregnant people report experiencing either physical or
sexual violence during their pregnancy and the prevalence increases to 20% when psychological violence is
included. IPV has widespread consequences, including physical injury, increased rates of chronic conditions,
poorer mental health, and death. Pregnancy is a particularly risky time for individuals in violent relationships:
Homicide is a leading cause of death for pregnant women in the U.S. and over half of pregnancy-associated
suicides involve intimate partner conflict. When a gun is available, the risk of a fatal (versus non-fatal) IPV
event increases 4-fold. Over half of women experiencing IPV are victimized multiple times over multiple
years, therefore meeting the definition of a chronic condition. Reproductive coercion (RC), a hallmark of
IPV, involves controlling contraception use, contraception sabotage, pressure to become pregnant, and
pregnancy decision-making. Prior work has shown people experiencing IPV often seek reproductive health
services and obtaining reproductive health care can reduce the risk of future violence. Today, over half of
women in the U.S. live in states with laws restricting access to reproductive health care, and many live in
states without IPV-related firearm restrictions. This timely proposal will examine relationships between state
law (reproductive health law; firearm law) and rates of IPV, IPV-related morbidity and mortality among
reproductive age people between 2015-2026. We propose to leverage the natural experiment created through
enactment of state laws restricting access to reproductive health services beginning in 2023. We will use data
from Medicaid, the Pregnancy Risk Assessment Monitoring System (PRAMS), the National Crime Victimization
Survey (NCVS), and the National Violent Death Reporting System (NVDRS), along with strong quasi-
experimental methods, such as comparative interrupted time series (ITS) or differences-in-differences (DD), to
characterize the relationships between state law and rates of IPV (Aim 1), IPV-related physical and mental
health outcomes (Aim 2), health service use (Aim 2) and IPV-related mortality (Aim 3). Our comparisons will
include 1) across state comparisons by state law; and 2) within state comparisons before and after law
enactment. We will conduct subgroup analyses to examine for law effect heterogeneity by race/ethnicity,
income, and community disadvantage. We hypothesize that state laws that restrict access to reproductive
health services will be associated with increases in IPV and IPV-related health outcomes and the impact will be
greater in some groups of people. This work will yield the best available evidence on the impact of state law on
IPV and health outcomes. Our proposal aligns well with RFA-OD-23-014 by examining the impact of state
laws on IPV (an understudied chronic condition) and mental and maternal health outcomes.

Public health relevance
Project Narrative Intimate partner violence (IPV) is common, with over 7% of U.S. women reporting physical or sexual violence, and/or stalking in the past year. Over half of women experiencing IPV are victimized multiple times over multiple years, therefore meeting the definition of a chronic condition. This proposal seeks to characterize the impact of state law on rates of IPV and IPV related health outcomes.